Quick and Accurate Measurements of HIV Broadly Neutralizing Antibody Susceptibility

PROJECT SUMMARY
HIV-infected individuals harbor viral quasispecies that differ in genetic sequences and susceptibility to broadly
neutralizing antibodies (bNAbs) targeting the HIV envelope (Env). Due to difficulties with current assays in
confirming viral sensitivity to bNAbs, most clinical trials enrolled participants without knowledge of their viral
susceptibility. Thus, an accurate and sensitive assay with quick turnaround (1-2 weeks) is needed. We propose
to approach this aim with two prongs: Aim 1, a phenotypic (Env function) assay for bulk Env neutralization
assessment and Aim 2, a genotypic (Env sequence) algorithm for high-throughput prediction of neutralization
susceptibility. We propose 10 HIV bNAbs targeting 5 distinct gp120 sites for assay development, with 2 non-HIV
human IgG1 antibodies as negative controls. Current assays are difficult because of two labor-intensive and
time-consuming procedures: Env single-genome amplification (SGA) and individual Env cloning. Aim 1 will
address the latter procedure required because the current TZM-bl neutralization assay cannot tease out bulk
Env clones that differ in bNAb susceptibility. Aim 1 will apply DNA barcoding to simultaneously track bNAb
sensitivity of hundreds of Env variants in a high-throughput manner. This will be achieved by a novel Env-
expressing lentiviral system in which each Env is linked to a unique barcode sequence. Aim 2 will address Env
sequencing, for which SGA is necessary because Sanger sequencing cannot sequence bulk templates. We
propose in Aim 2 to apply a third-generation sequencing technology, Nanopore sequencing, for effective bulk
template sequencing and develop machine learning models for a fast and reliable prediction algorithm.
Combining with the ample bNAb neutralization data from literature and Aim 1 of this project, trained
computational models can be fast, accurate, and high-throughput to predict bNAb susceptibility. Since the
detection of a low yield of functional Env sequences and minority variants from participant’s HIV DNA reservoir
is essential, we propose in Aim 3 to investigate whether a virion capture assay could be applied to enrich
functional Envs. We will also apply a DNA analysis to enrich minor variants from the viral reservoir. We have
biospecimens stored onsite and access to a wide distribution of HIV subtypes from the AIDS Clinical Trials Group
(ACTG) and HIV Vaccine Trials Network (HVTN) biorepositories for assay development and validation. All
proposed R61 Aims have clear milestones defined and the R61 assays will be developed with streamlined and
standard operating procedure (SOP) for adaptation to clinical labs. The Columbia Clinical Trials Support
Laboratory is fully equipped and staffed to perform the SOPs and provide input and validation on assay
performance. Successful development of an accurate and sensitive bNAb susceptibility assay with quick
turnaround will alter the enrollment for bNAb trials and greatly improve clinical development of bNAb products.

Public health relevance
Project Narrative PUBLIC HEALTH RELEVANCE: Early clinical trials have demonstrated the potential for bNAbs to treat and prevent HIV infection; however, in clinical trials, participants are enrolled without knowledge of their viral susceptibility to bNAbs, which in turn adversely affects bNAb clinical evaluation. We aim to develop accurate assays that measure viral susceptibility to bNAbs at the point-of-care with fast turnaround so that pre-existing and emerging resistance can be identified timely. Such information will greatly impact and improve trials to determine the true efficacy and cutoffs for clinical use of bNAbs.